Administrative Core

The program director of the Center will be Raghu Kalluri, who will have the primary responsibility for overseeing all research activities, administrative and financial acfivities of the projects within the center, and also facilitate interactions with the TMEN steering committee and other TMEN networks. Pier Paolo Pandolfi and David Scadden will assist in these activifies and make themselves available to TMEN steering committee meefings and in fostering interacfions with other TMEN participants. Raghu Kalluri has experience with the management and administration of multi-investigator translafional studies. He is currently the Chief of division and in-charge of 42 clinicians and researchers. He will seek confinual input, advice, and approval from the Center internal advisory Committee comprised of co-leaders and investigators of each major project and other members ofthe BIDMC Harvard Medical School'community. He will seek the advice and the guidance of the External Advisory Committee as needed and also during organized annual meefings with the committee.